Genomic Acquisition and Analysis (GAA)

ABSTRACT: GASP CORE
Genetic studies have provided clear evidence that virtually all human traits studied in biomedical research,
including disease susceptibility, treatment responses, relapses and side effects, are influenced by genetic
makeup. It is, therefore, essential to incorporate genetic information in medical research and practice to
achieve optimal outcome. As genetic information is encoded in genomic DNA, to understand the genetic
architecture of a disease or trait, or to dissect the genetic makeup of an individual, we have to conduct DNA
sequencing of the genome of that individual. In this personalized medicine focused COBRE application, we
intend to integrate and disseminate genetic and genomic data, and apply them to personalize health issues
proposed by individual projects. The genome analysis and sequencing pipeline (GASP) core is designed to
support individual projects by providing services for DNA/RNA sequencing, data integration, dissemination and
analyses. Since bioinformatics and biostatistics have become a critical component in genomic and genetic
studies, the core will also provide expertise and services to support each project to accomplish its goals. The
specific aims of the core are:
1. To conduct genomic experiments to acquire data required by each individual project. These
experiments could be the sequencing of exome/whole genome, or enriched portion of genome
(methylation or targeted genes/pathways), genotyping of specified genetic variants or profiling of gene
expression.
2. To provide bioinformatics support for individual projects. This service includes data quality control, the
establishment of analytic and annotation pipelines and the generation of analysis-ready data sets for
downstream analyses.
3. To provide genetic analysis service to individual projects. These services include the identification,
annotation and characterization of genetic variants, evaluation of genetic risks, and genetic association
analyses.
4. To assist and coordinate other omics services required by individual projects. Project 3 will analyze
blood samples for protein components and metabolites. We do not have sufficient resource in this
COBRE to conduct these proteomics and metabolomics analyses. Other projects and pilot studies may
need other omics services as well. Therefore, we propose to coordinate with the project leaders and
help them to find appropriate vendors for these services.

Public health relevance
PROJECT NARRATIVE: GASP CORE Genetic studies have made significant progress in recent years. One of the major findings is that all human traits, including many heath related traits, such as disease predisposition, treatment response, relapse and side effect, are all influenced by genetic makeup. This makes the dissection of individual's genome a necessary and essential task in order to achieve the best effects of disease prevention, diagnosis, and treatment. In this personalized medicine focused COBRE application, the Genome Analysis and Sequencing Pipeline core is designed to help and support individual projects to acquire genomics and genetics data and integrate these data for the projects so that each project can accomplish its goals in personalized characterization and analysis of focused health issues.